Transcriptional Regulation of Lung Cancer Identity

Project Summary
Lung adenocarcinoma, the most common cause of cancer death worldwide, exhibits substantial heterogeneity
in cellular identity, or differentiation state. In this disease, cancer cell identity correlates with critical clinical
parameters, including patient prognosis, intrinsic sensitivity to therapy, and acquisition of drug resistance.
Thus, there is an unmet need to obtain a comprehensive understanding of mechanisms controlling LUAD
identity. A major rationale for this proposal is that a mechanistic understanding of the complex interplay
between lineage specifiers and oncogenic signaling pathways in LUAD must be achieved before such
therapeutic strategies can be developed. The immediate goal of this application is to test the central hypothesis
that lineage specifiers and oncogenic signaling pathways coordinately modulate LUAD identity and growth.
This hypothesis will be tested in the following specific aims via an integrative experimental approach employing
genetically engineered mouse models (GEMMs), organoid cultures, human PDX models/cell lines and clinically
relevant pathway inhibitors: (1) Identify mechanisms by which FoxA1/2 promote tumorigenesis and activate a
mixed-lineage state in NKX2-1-positive lung adenocarcinoma. (2) Identify mechanisms by which oncogenic
signaling pathways regulate identity in NKX2-1-negative lung adenocarcinoma.

Public health relevance
Project Narrative Lung cancer is the leading cause of cancer death worldwide, and lung adenocarcinoma is the most frequently diagnosed subtype of this disease. The proposed research will investigate molecular regulators of identity in lung adenocarcinoma and provide fundamental knowledge required for the design of integrative therapeutic strategies that target this disease on the basis of differentiation state-specific vulnerabilities as well as actionable mutations.